Genetic basis of virus induced Biliary Atresia

Project Summary/Abstract
Biliary atresia is the most common cause of pediatric end stage liver disease and the number one indication for
pediatric liver transplantation. The presence of pathogenic viruses in the liver of afflicted children led to
perinatal viral infection as a proposed etiology for biliary atresia as this infection triggers an immune mediated
destruction of the biliary epithelium leading to liver fibrosis and ultimately, cirrhosis. The murine model of biliary
atresia supports a viral pathogenesis as newborn mice infected with Rhesus rotavirus (RRV) develop portal
inflammation extrahepatic bile duct obstruction; however, it is accompanied by high mortality rates precluding
the ability to study hepatic fibrosis. We have developed two novel modified virus strains, TR(VP2, VP4) and
RRVVP4-K187R, which induce biliary obstruction accompanied by high rates of hepatic fibrosis. We have
demonstrated infection with these strains causes bile duct obstruction and hepatic fibrosis that mirrors the
human phenotype better than conventional models, including carbon tetrachloride and bile duct ligation. These
strains allow us to mechanistically interrogate the post-obstructive fibrotic pathway, a critical next step in the
understanding of BA pathogenesis. We will use these strains to determine how infection of cholangiocytes
alters the innate immune response leading to the recruitment and activation of monocytes/macrophages. We
will also ascertain these modified rotavirus strains’ ability to infect and activate hepatic stellate cells inducing
liver fibrosis. These complementary approaches will generate new insight into virus-induced biliary atresia and
liver fibrosis.

Public health relevance
Project Narrative Biliary atresia is the most common cause of pediatric end stage liver disease and the primary indication for pediatric liver transplantation. Because pathogenic viruses have been found in the livers of afflicted children, a perinatal viral infection is a proposed etiology for biliary atresia as this infection may induce immune mediated destruction of the biliary epithelium leading to obstruction and liver fibrosis. Our goal, using a novel set of modified rotavirus strains, is to determine how rotavirus infection activates the innate immune system affecting the microenvironment of the hepatobiliary system driving liver fibrosis enabling the development of new treatment strategies to alter the course of this challenging disease.